A platform for T-cell receptor mimic antibody generation modeled using pHLA-A*11:01 KRAS G12D

ABSTRACT
This Phase II proposal is an ambitious advancement for precision oncology, focusing on
the discovery and validation of T cell receptor mimic antibodies (TCRms) targeting
mutation-associated neoantigens (MANAs) specific to KRAS mutations. More specifically
the KRASG12D mutation in the HLA-A*11:01 allele. This project, rooted in the innovative
'Epivolve' technology, aims to enhance the specificity and efficacy of immunotherapies by
developing novel antibodies that can distinguish between mutant and wild-type KRAS
peptides. The significance of this research lies in its potential to overcome the
longstanding challenge of targeting intracellular oncogenic proteins, which are otherwise
inaccessible to conventional therapies. Upon successful completion, this strategy could
transform the therapeutic landscape for numerous cancers characterized by KRAS
mutations and other neoantigens, offering highly targeted treatments with potentially
fewer off-target effects and significantly improved patient outcomes in the oncology field.

Public health relevance
NARRATIVE This project seeks to revolutionize oncological treatment by developing T cell receptor mimic antibodies (TCRms) that accurately target KRAS mutation-associated neoantigens (MANAs), pivotal in many cancers yet historically challenging to treat. Leveraging the novel 'Epivolve' technology, the research will focus on enhancing antibody specificity and reducing off-target effects, providing a significant advancement in precision medicine. The successful implementation of this strategy promises to improve clinical outcomes for cancer patients with KRAS mutations, representing a significant breakthrough in targeted cancer therapy.